Drug Development for Alzheimer's neuroinflammation

Project Summary
Alzheimer’s disease (AD) affects around 6 million Americans and imposes a burden of $320
billion on the US economy. Since 2003, very few medications have been approved for AD.
Neuroinflammation is one of the leading mechanisms for AD pathology affecting several brain
cell types and is an active target for treatment. One of the promising targets for
neuroinflammation is the calcium-dependent phospholipase A2 (cPLA2) which regulates
neuronal membrane excitability, polyunsaturated fatty acid metabolism, and vascular integrity.
Increased activation of cPLA2 in the brain is associated with eicosanoid inflammatory lipid
profiles and is observed in AD, post-stroke, Parkinson, spinal cord injury, and traumatic brain
animal models. Importantly, genetic or pharmacological reduction of cPLA2 activity ameliorates
disease severity across these models. Our group has demonstrated that carrying the APOE e4
(APOE4) allele, the strongest genetic risk factor for AD, activates cPLA2 in the brain. In
postmortem human brain tissues, we reported eicosanoid lipid activation profiles consistent with
cPLA2 activation in APOE4 AD. Despite the strong preclinical signals, no brain penetrant cPLA2
inhibitors advanced to clinical trials. Our team has established a structure-based drug discovery
platform and used it to identify new lead compounds that inhibit cPLA2, confirming their potency
in vitro and in cells and brain penetrance. Our current lead has an affinity, safety, and blood-
brain barrier penetration consistent with drug-like properties and initial SAR suggesting high
optimization potential. Moreover, we developed a brain imaging tool based on the uptake of
arachidonic acid in the brain to assess the efficacy of cPLA2 inhibition in vivo. Using these
platforms, we plan to establish a comprehensive SAR for our main and backup lead series and
develop a screening funnel. In close collaboration with consultants and contractors, this
screening funnel will then be employed to optimize the lead potency, selectivity, ADMET, and
PK properties relevant for cPLA2 inhibitors, including in vivo potency and minimal toxicity
profiles. This would allow for the selection of clinical candidates for the development of IND-
enabling studies and preparation of IND targeting AD neuroinflammation.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is a debilitating aging disease with no effective therapies. Brain inflammation is one of the key mechanisms present in the Alzheimer’s brain. We propose the development of AD therapies based on reducing the activity of calcium-dependent phospholipase A2, a key driver of brain inflammation.